Policy Impact Core

ABSTRACT – POLICY IMPACT CORE
The Policy Impact Core supports the CHIPTS mission by promoting policy-relevant research, training, and
dissemination activities that address mental health and substance use disorders, social and structural
determinants of health (hereafter “comorbidities”), and health disparities among people living with or at
elevated risk for HIV. The core aims to leverage policy to address issues and to translate scientific advances
into actionable policy items; activities that impact the gaps between targets and outcomes that can be
attributed to systemic inequities linked with comorbidities. The core uses data and scientific findings to highlight
systemic disparities in HIV prevention and treatment outcomes across racial/ethnic, sexual orientation, gender,
and mental health/substance use disorder groups that are overrepresented among socioeconomically
disadvantaged populations. Focusing on populations made vulnerable by changes to health policy,
experiences that lead to medical mistrust and over engagement with the criminal justice system, the core
contributes to CHIPTS research themes and stewards policy-level change in response to new developments in
science, policy, and practice towards equitable ends. Through elevating community-informed research
addressing factors that negatively and disproportionately affect Black, Latinx, and Native American populations
with comorbidities, the core supports efforts to use policy to increase access and equitable opportunities for
combination HIV prevention and treatment. These points illustrate the unique perspective and focus the core
brings to the overall center. The specific aims are: (1) Science: To promote and evaluate policy change in
response to scientific research that addresses barriers and facilitators to equitable dissemination and
implementation of emerging innovations, especially regarding HIV-related disparities and people with or at risk
for HIV with comorbidities and/or criminal justice system involvement; (2) Networking: To develop, strengthen,
and maintain channels of communication with policy makers, community stakeholders, investigators, and state
and local public health entities; and (3) Capacity Building: To build the capacity of investigators, including
domestic and international partners, to implement and evaluate evidence-based policies that aim to increase
contributions of emerging innovations to end the HIV epidemic. The core works to promote policy-relevant
research, training, and dissemination that address mental health and substance use disorders, social and
structural determinants of health, and health disparities among people living with or at high risk for HIV. The
gap between targets and outcomes can be attributed to systemic inequities in social determinants of health.